Small Molecule Drug Development Shared Resource

SMALL MOLECULE DRUG DEVELOPMENT SHARED RESOURCES
PROJECT SUMMARY/ABSTRACT
The Small Molecule Drug Development Shared Resource (Drug Development SR) was established in
September 2015 to address the lack of critical infrastructure enabling small molecule screening and the
identification of small-molecule probes. The mission of the Drug Development SR is to enable investigators to
optimize robust assays in 384-well format and to screen these assays across large chemical libraries to identify
new small molecules that may be the starting point for innovative cancer therapeutics. In the first year, a wide
range of investigators from Case Western Reserve University (CWRU), University Hospitals (UH), Cleveland
Clinic (CC), a collaborator from Duke University, and a Cleveland biotech startup utilized the Drug
Development SR, testifying to the large demand for small-molecule screening.
Since its establishment, the Drug Development SR has worked with 17 investigators, approximately 65% of
whom are Case CCC members, accounting for 79% of total usage, and representing 4 of the 7 Case CCC
Programs. The Specific Aims of the Small Molecule Drug Development Shared Resource are to:
1. Provide assay development and high-throughput screening services, using both high-throughput and high-
content approaches to screen libraries of known bioactive compounds (bioactives) and diverse screening
libraries.
2. Share expertise to design and optimize robust high-throughput assays tailored to specific projects, by
consultation between the PI, the Director, and the Managing Director to inform project design, execution,
and troubleshooting.
3. Train new users, including PIs, research scientists, and trainees, in proper and safe operation of the SR's
automation equipment at reasonable cost, and welcome/include their participation during assay
development and execution.
4. Offer advice and guidance to advance hits to leads using cheminformatics and medicinal chemistry, by
providing recommended strategies for prioritizing hits, and linking investigators with medicinal chemists.
5. Guide users toward SRs and potential collaborating investigators in Case CCC Programs with
complementary capabilities relevant to drug development as projects evolve, including connections to
researchers with expertise in proteomics, in vitro and in vivo pharmacology, and in vivo testing.
Moving forward, the Drug Development SR aims to complete 3 or more full high-throughput screens per year
and 6 or more pilot screens to maintain a pipeline of robust assays for future large-scale screens. Additionally,
the facility will expand its equipment set to provide redundancy in several key instruments, and will expand its
screening libraries to 100,000 small molecules to match typical screen sizes performed in other academic
screening centers.